Molecular mechanism of cardiac inflammation and dysfunction in Pseudomonas aeruginosa infection

Nosocomial infection is a persistent problem in healthcare today and in the intensive care units, accounting for
over 200,000 deaths annually. Ventilator-associated pneumonia (VAP) develops as a complication in 8 – 28%
of patients receiving mechanical ventilation, represents approximately 50% of ICU acquired infections.
Specifically Pseudomonas aeruginosa (P.a.) infections account for up to 20% of all cases of hospital acquired
pneumonia with mortality rate of ~30%. More than 60% of sepsis patients in ICU show evidence of cardiac
dysfunction and acute bacterial pneumonia stresses the heart and suppresses ventricular function. Also many
bacterial virulent factors activate TLRs in cardiomycytes and suppress the myocyte contractile function.
Although cardiac dysfunction caused by inflammation during infection is thought to be the key driver of
mortality in ICU pneumonia patients, broad anti-inflammatories do not effectively prevent death. Thus,
understanding the cellular components involved in the cardiac inflammation and their impact on myocyte and
fibroblast function would assist in the prevention of cardiac dysfunction in pneumonia patients. We have
discovered that the infiltration of activated myeloid cells into the hearts of P.a. infected mice induces cardiac
inflammation and apoptosis that leads to phenotypic switch of cardiac resident macrophages and causes
cardiac damage. Specifically, we identified that P.a. infection induces miR155 expression which targets many
genes required for myocyte contractile function. We are the first to discover the link between cardiac
macrophages (effector molecule miR155) and myocyte contractile dysfunction and fibroblast activation
(fibrosis) during bacterial infection. Thus we hypothesize that the infiltration of activated myeloid cells shifts
anti-fibrotic cardiac resident macrophage (MHC-IIlow) into pro-fibrotic macrophages (MCH-IIhigh) through cardiac
inflammation and apoptosis, which results in myocyte contractile dysfunction and fibroblast activation. The
miR155 functions as a global regulator of myeloid cell infiltration and thus prevents the cardiac macrophage
phenotypic switch. The goals of this research program are to 1) Define the molecular mechanism of myocyte
contractile dysfunction and fibroblast activation during P. aeruginosa infection. 2) Investigate the role of cardiac
macrophages in activation of intrinsic signaling pathways that cause cardiac dysfunction during sepsis. 3)
Determine whether localized inhibition of cardiac inflammation preserves the heart function in invasive bacterial
infections. We will use human inducible pluripotent stem cell derived cardiomyocytes (hiPSC-CMs), human
cardiac fibroblast, and human monocyte derived macrophages to test our hypothesis in vitro. For in vivo
studies we will use knockout mouse models to accomplish our goals. Overall, the mission of my laboratory is to
identify the important regulatory pathways and effector molecules to create therapies for cardiac dysfunction in
pneumonia patients. Our basic research discoveries will jump-start the development new approaches and
drugs to treat cardiac dysfunction in sepsis.

Public health relevance
Public Health Statement: Gram-negative bacteria Pseudomonas aeruginosa is one of the dominant pathogen present in patients with bacteria induced sepsis and myocardial dysfunction occurs in over 40% of septic patients and is a major contributor to morbidity and mortality. We have developed a pneumonia mediated bacterial infection model to study the yet to unknown role of cardiac macrophages in myocyte contractile dysfunction and fibroblast activation, which leads to cardiac fibrosis and heart failure. This study will allow us to develop new effective strategy to treat cardiac dysfunction during bacterial pneumonia.